6/14 APOL1 Long-term Kidney Transplantation Outcomes Network (APOLLO) Clinical Center

PROJECT SUMMARY
We submit this application in response to RFA-DK-22-506. The North East Consortium for Transplant Outcomes
in APOL1 Kidney Recipients (NECTAR), APOLLO Clinical Center 6 (CC6), is a current member of the APOLLO
Consortium - a national consortium of transplant programs established in 2017, which collaborates with United
Network for Organ Sharing, Association of Organ Procurement Organizations, American Society of
Histocompatibility and Immunogenetics and Scientific Registry of Transplant Recipients. The goal of this
consortium is to prospectively evaluate the role of APOL1 kidney risk variants on graft outcomes in kidney
transplant recipients (KTRs) and kidney function of living donors (LD) with African ancestry. The APOL1 risk
variants G1 and G2 have a prevalence of 30% and 8%, respectively, among African Americans (AAs). Presence
of homozygous risk variants increases the risk of non-diabetic end-stage kidney disease by 7-10 fold.
NECTAR/CC6 oversees 6 Engaged transplant centers, Icahn School of Medicine at Mount Sinai (ISMMS), Weill
Medical College-NewYork Presbyterian (WMC-NYP), New York University Medical Center, Northwell Health,
SUNY-Upstate Medical University, and 2 Non-Engaged transplant centers, SUNY- Stony Brook University
Hospital and Robert Wood Johnson University Hospital. Our 8 centers have enrolled 125 recipients of
deceased donor kidneys, 30 living donor recipients, and 35 living donors with African ancestry and have
collected >90% the DNA for the total cohort of 190 enrollees. Our site has established regular communication
to monitor CC6 enrollment and oversee biospecimen collection and data entry at our own site and that of our
network centers to ensure accurate timely completion of forms. The goal of this current proposal is to continue
collaboration with the APOLLO Consortium to understand the potential modifiers of graft loss associated with
APOL1 kidney risk variants, identify biomarkers predictive of graft loss, and expand the database of LD with
African ancestry to better define kidney donor risk. In Phase 2, we will (1) re-engage/reconsent ALL study
participants enrolled in Phase 1 to collect long-term data on kidney function outcomes in KTRs and LDs, including
measurement of urine albumin to creatinine ratios, (2) obtain comprehensive data on post-transplant clinical
course of ALL KTRs to understand potential second hits, (3) collect additional urine and blood biospecimens
beyond 1 year post-transplant and kidney biopsy slides associated with diagnostic or surveillance kidney
biopsies at the main CC6 sites (ISMMS and WMC-NYP), (4) recruit new LD with African ancestry at ISMMS and
WMC-NYP, and (5) collaborate with Scientific Data and Coordinating Center to return genotype results of all
interested participants accurately and safely while adhering to rules of privacy of protected health information.
NECTAR/CC6 will participate in the Steering Committee and develop the necessary protocols for accurate and
complete data capture that will address the goals of this collaboration.

Public health relevance
PROJECT NARRATIVE The gene APOL1 has been associated with increased risk of chronic kidney disease in African Americans. North East Consortium for Transplant Outcomes in APOL1 Kidney Recipients (NECTAR) Clinical Center, APOLLO CC6, will study the impact of this gene on long-term outcomes in renal transplant recipients that receive a kidney from an AA donor and on renal function of AA living donors by leveraging the infrastructure and collaborations established in Phase 1. In Phase 2, we will maximize long-term clinical data capture, recruitment of AA living donors and biospecimen collection according to the goals of the Consortium.